IGF::OT::IGF SERVICES TO: (1) TO PROVIDE EXPERTISE IN STATISTICAL MODELING APPROACHES TO ESTIMATE CONFIDENCE INTERVALS FOR RANKING COMPOSITE HEALTH INDEXES, AND (2) PROVIDE SUPPORT TO THE KENTUCKY TUM

Confidence Intervals for Ranking Composite Health Indexes across Geographic Units